Randomized Trial of Telehealth vs Conventional Hearing Care Delivery in the ACHIEVE Study

PROJECT SUMMARY
Hearing loss is a chronic condition prevalent in two-thirds of adults >70 years and may be a potentially
modifiable risk factor for adverse health outcomes including dementia. However, uptake and sustained use of
hearing aids in adults is low, with <20% of older adults with hearing loss reporting use, among whom up to 30-
40% may discontinue hearing aid use over time. These limitations may stem in part from the reliance of the
current best-practice model of hearing healthcare (HHC) on clinic-based visits that requires multiple in-person
sessions between an audiologist and a patient for all ongoing technical and self-management support services.
Incorporation of asynchronous and synchronous telehealth into HHC to complement clinic-based visits would
allow for routine troubleshooting of communication challenges, hearing aid technical issues, and reinforcement
of self-management support strategies. Determining if a HHC model that incorporates audiological telehealth
improves long-term hearing aid use and other patient-centered outcome measures has direct implications for
both future clinical care standards and ongoing Medicare legislative bills pertaining to HHC coverage. Our
interdisciplinary consortium of investigators has a singular opportunity to evaluate the potential benefits of a
telehealth audiology model on long-term hearing aid use and other outcomes in a large cohort of racially-
diverse, community-dwelling older adults who are existing hearing aid users. In the ongoing Aging & Cognitive
Health Evaluation in Elders (ACHIEVE) randomized trial, we recruited 977 adults ages 70-84 with untreated
mild-to-moderate hearing loss from January 2018 to October 2019 who were randomized 1:1 to a hearing
intervention (i.e., conventional clinic-based delivery of hearing services and technologies) versus a successful
aging education control intervention. Participants are now being followed for 3 years post-randomization at the
four ACHIEVE field sites, and the goal of this NIA-funded multisite trial (R01AG055426) is to determine if
hearing loss treatment versus an aging education control intervention reduces cognitive decline. From 2021-
2022, as participants in the hearing intervention group (n=490) complete their pre-specified three years of
follow-up in the ACHIEVE trial, we propose to recruit these existing hearing aid users and randomize them to
receive either continued conventional clinic-based delivery of hearing care services or a model that
incorporates telehealth. At 1 year post-randomization, the primary outcome (hours of hearing aid use) will be
contrasted between the two groups, and participants in the conventional HHC arm will then cross-over and
also receive telehealth HHC. All participants will continue to be followed for 2 years post-randomization. Aim 1:
To compare the effect of the telehealth versus conventional HHC delivery model on hours of hearing aid use
(primary outcome) and other patient-centered hearing and communication outcomes at 1 year post-
randomization. Aim 2: To compare the effect of the telehealth versus the conventional HHC delivery model on
secondary outcomes of social, mental, physical, and cognitive functioning at 1 year post-randomization.

Public health relevance
PROJECT NARRATIVE Understanding if a telehealth versus a clinic-based hearing care service delivery model can lead to improved hearing aid use and communicative function among older adults using hearing aids is important for guiding clinical care standards and policy decisions regarding hearing care coverage in the U.S. The goal of this proposal is to conduct a randomized trial of these two hearing care models in a follow-up study to the ongoing NIA-funded Aging and Cognitive Health Evaluation in Elders (ACHIEVE) study.